Smart driving technology for non-invasive detection of age-related cognitive decline

Dementia and other age-related neurodegenerative diseases such as Alzheimer’s Disease (AD) and Alzheimer’s
Disease Related Dementias (ADRD) cause a marked decrease in quality of life for patients, an increased burden
of care, and, for adults over 65, are a leading cause of death. Therefore, better understanding of the nature of
dementia is vital to the development and assessment of effective treatment options. Despite the grim lookout,
clinical research suggests that intervening the disease before irreversible brain damage occurs is a key step to
improve the outcomes of AD/ADRD. Specifically, Mild Cognitive Impairment (MCI), the stage before the onset of
dementia, could provide the largest “window of opportunity” for lifestyle interventions that can delay/prevent MCI
and dementia. Our team has reported lifestyle changes which brings a window of opportunity for the disease
treatment prior to irreversible brain damages.
Several studies have demonstrated a relationship between MCI and driving performance including driving
behaviors. Although driving features provide an unobstructive window of opportunity to test the brain
responses under everyday cognitive challenges, it is currently unrealistically costly and labor-intensive to be
widely deployed. We hypothesize an unobstructive, continuous, economical system capable of assessing
driving signatures that can detect early stages of neurodegenerative diseases would offer a window to reverse
AD and ADRD. In this work, we propose to develop and validate an unobtrusive and car-make agnostic
sensing system, named Smart Pad, for daily assessment of driving indicators under free-living conditions. The
system: 1) automatically records and analyzes data with the integrated biosensor array and a mobile App to
evaluate driving; 2) uses the biosensors array to detect not only driving habits, but also new driving
performance indicators and unprecedented driver’s biomarker (posture and metabolic rate), which are
correlated with detrimental cognitive stages, and 3) is empowered by an Artificial Intelligence (AI) algorithm to
predict cognitive performance and MCI. In this Phase I proposal, we will leverage the Smart Pad prototype
design that we have developed and optimize it to for the diagnosis of driver’s cognitive status.
The TF Health Co.-ASU-BNI team will work together to build the unobtrusive, vehicle-based sensing
system for daily assessment of driver performance and biometrics, and age-related cognitive decline to
develop new technology for early diagnosis of dementia in free-living condition, seeking to improve patient care
options and promote cognitive decline prevention interventions.

Public health relevance
The proposed project targets the detection of early neurodegenerative diseases, before the onset of dementia, to delay/prevent the growing and debilitating Alzheimer Disease and Alzheimer’s Related Dementias (AD/ADRD) through affordable and practical lifestyle interventions. Our prior work and literature strongly support our approach, and if successful, not only will we learn more about early detection and prevention in free-living condition, we can bring an affordable, easy-to-use, tool to healthcare professionals and the general public to fight AD/ADRD.